Laboratory to Perform Assays of Coagulopathy Biomarkers for the National Cancer Institute’s COVID-19 in Cancer Patients Study (NCCAPS)

Lab will conduct coagulopathy assays for NCI to analyze as part of a correlative science objective in NCI COVID-19 in Cancer Patients Study (NCCAPS): A Longitudinal Natural History Study, ClinicalTrials.gov Identifier: NCT04387656 https://clinicaltrials.gov/ct2/show/NCT04387656